Center for Clinical and Translational Science and Training

Contact PD/PI: Heubi, James E
OVERALL
ABSTRACT
The Center for Clinical and Translational Science and Training (CCTST) was established at the University of
Cincinnati (UC) in 2005 and awarded an institutional Clinical and Translational Science Award (CTSA) in 2009.
Since that time, basic science research, genomics, technology, and drug development have made remarkable
progress, warranting new solutions for translating research to practice. Concurrent with these discoveries, the
CCTST has created innovative solutions for our program functions, including biomedical informatics,
biostatistics and study design, regulatory and ethics, community engagement and team science, recruitment
and support for clinical trials, patient care interactions, pilot grants, and translational workforce development.
With the competitive renewal application and the current revision and creation of CCTST 3.0, we will continue
to utilize the guiding principles of learning health systems to develop stronger bidirectional relationships with
our community and expeditiously bring discoveries to application. Indeed, we intend to capture this tremendous
opportunity to better align the clinical/operational mission of the health system with the research mission of the
University and its affiliates. The overarching goal of the CCTST is to maximize the impact of clinical and
translational research to improve individual and population health locally and nationally, through 1) engaging
stakeholders to collaboratively translate research into improved health care practice and community wellness
across the lifespan; 2) developing a diverse, multidisciplinary workforce to conduct innovative, team-based,
community-engaged translational research and to disseminate and implement findings that will improve health
outcomes and reduce disparities; and 3) optimizing the use of biomedical data across the translational
research continuum using innovative data science methods to advance discovery, dissemination, and
implementation. For each of the programs and optional functions, these aims serve as the basis for planned
innovative activities and to facilitate cross-core integration. We specifically target learning health systems as an
optional module for this application because of the expertise available at Cincinnati Children's Hospital Medical
Center that can be leveraged across the CCTST and its health care affiliates. In fulfilling these aims, CCTST
3.0 will catalyze the translation of discoveries into improved health outcomes locally and nationally.
Page 307
Project Summary/Abstract
Contact PD/PI: Heubi, James E
NARRATIVE
The CTSA consortium has matured to the point that 57 sites are working together to advance science with the
goal to improve the health of the nation. The University of Cincinnati Center for Clinical and Translational
Science and Training has become a portal of entry for clinical and translational investigators to obtain support
for the completion of their studies across the spectrum of translational science, from the bench to population
health. With this revised renewal application, we will develop additional innovative methods to produce high
quality research, share these discoveries, collaborate with other CTSA hubs, and have a measurable impact
on the health of our community using the principles of a learning health system.
Page 308

Public health relevance
Project Narrative